Growing and Sustaining Community Change Researchers in STEM

PROJECT SUMMARY/ABSTRACT
In order to increase diversity in STEM, there is a critical need to develop programs that
meaningfully engage underrepresented groups in relevant STEM experiences. The overall
objective of this proposal is to engage Black, Latinx, and Appalachian high school students
and their teachers in a community-based participatory research (CBPR) program focused on
substance use and mental health in their local communities. CBPR is an orientation to scientific
inquiry that values shared decision-making and equitable collaboration between community
and academic partners. In this case, CBPR will engage students in the role of scientist, with
respected contextual expertise and perspective that will not only improve the quality of the
research but also increases the potential for positive social change. The rationale for this
proposal is that engaging students in CBPR to investigate substance use and mental health in
their own communities will allow youth to experience how scientific practices and STEM skills
can address real-world problems relevant to their communities. By facilitating meaningful
engagement in behavioral health and addiction science research, we will reach our long-term
goal of increasing STEM workforce diversity. Our program has three specific aims: (1) Promote
students’ interest in and understanding of scientific research by engaging students as co-
researchers in original scientific investigations of behavioral health in their local communities;
(2) Develop students’ scientific research skills, scientific communication skills, researcher
identities, and science self-efficacy by engaging students at each step of the research
process including presentation and publication of findings; and (3) Develop high school
teachers’ capacities to support youth participation in scientific research and scientific
communication through interactive professional development. Expected outcomes for students
include increases in STEM knowledge and skills, interest in scientific research, and STEM
efficacy; and a desire to pursue a biomedical, behavioral or clinical research career. We will
accomplish these aims through a cycle of activities that each year engages a new group of
students as co-researchers in investigations of substance use and mental health in their local
communities. Throughout the activity cycles, students will collaborate with and receive
mentorship from our extremely diverse faculty team. Participation by approximately
286 students and 6-10 teachers over the course of the program will significantly impact the
representation of Black, Latinx, and Appalachian individuals in behavioral, biomedical, and
clinical research careers.

Public health relevance
PROJECT NARRATIVE The overall objective of this proposal is to engage Black, Latinx, and Appalachian students and teachers across three schools in a community-based participatory research (CBPR) program focused on substance use and mental health in their local communities. Youth who collaborate as shared decision-makers in research are more likely to develop intrinsic interest in STEM research professions. By facilitating meaningful engagement in behavioral health research, we will reach our long-term goal of increasing economic, geographic, and racial diversity in the biomedical, behavioral, and clinical research workforce.